Promoting Child and Adolescent Research During Training

Psychiatric disorders are common in childhood and cause significant morbidity, mortality and disability. There
is a critical shortage of physician-scientists in child and adolescent psychiatry (CAP) to address this significant
problem. Unfortunately, there are a dearth of programs that provide significant research training, forcing CAP
fellows who desire a research career to commit to an additional 2-3 years of postgraduate research training
beyond their CAP fellowship. This proposed R25-funded Child and Adolescent Psychiatry Research Training
Track (CAP-RTT) will fill this critical training gap and national need. It will train the next generation of physician-
scientists in CAP research and accelerate their trajectories to independent, productive research careers. This
two year program, with an optional third year, will pair substantial dedicated research time with excellent
clinical training in our CAP fellowship. Our Division provides an ideal setting to combine superb research and
clinical training. Our CAP fellowship and Triple Board Program have a long history of attracting excellent
trainees providing unparalleled training. We have a pool of potential CAP researchers for the CAP-RTT. The
number of research-oriented residents potentially available to our program, stimulated this application. In 2019,
the Division received more than $15 million for active grants (representing over $38 million in all years of
funding for those projects). The Division's pioneering research in psychopathology, children's sleep, infant
development, psychophysiology, and HIV clinical interventions has translated into new and effective treatments
for children and their families. Other areas of interest include neuroscience, genetics, social science,
prevention, health disparities, and health services research. Our faculty are skilled mentors in the Division's
two NIMH T32 programs and participate in many other research training programs at Brown. Our program will
combine an intensive longitudinal mentored research experience with an individualized research didactic
curriculum and career development activities in a rich, multidisciplinary environment. The program will contain
substantial protected research time, individualized mentored research training, a specialized didactic research
curriculum, career development experiences for trainees, and a comprehensive evaluation component of the
fellows and the program.

Public health relevance
There is a critical shortage of physician-scientists to address the significant problems caused by child and adolescent mental health illness. This proposed research program will fill a critical gap in training and a national need. Our program will pair substantial dedicated research time with excellent clinical training in our child and adolescent psychiatry fellowship.